Enhancement of Human Immune System Development in Mouse Models

Animal models are essential for studying biological processes underlying human health and diseases and
developing safe and effective therapeutic approaches before human clinical trials. We dedicated our proposal to
developing and characterizing new and significantly improved genetically modified animal models for human
immune system establishment in mice. The conception of genetically engineered mice to engraft functional
human immune systems opened a new horizon to study human-specific infections and associated multiorgan
pathology. These models enable the successful engraftment of stem cells of non-fetal human tissue origin,
including ex vivo engineered cells. Humanized mice are permissible to direct infection or challenges with wild-
type human pathogens. Moreover, human cells isolated from experimental models became valuable for
analyzing transcriptional and metabolic changes during infections and treatment. Thus, humanized mice have
allowed researchers to address questions related to the treatment and prevention of important diseases like
human immunodeficiency virus, hepatitis viruses (HIV/HBV/HDV/HCV), and newly emerging pathogens. Such
models are directly applicable to study human health and diseases like human-specific infections, cancer
immunology, transplantation of genetically modified human stem cells, and phenotypic characterization of
various organ systems by omics approaches.
We designed a new mouse background to avoid common cytokine gamma chain knockout and preserved
secondary lymphoid organs for the efficient population with human immune cells. Nuclear factor interleukin-3
(Nfil3; also known as E4-binding protein 4, E4Bp4) transcription factor will be knocked out by CRISPR/Cas
technology. By introducing human receptors and chemokines involved in the formation and growth of lymphoid
tissues, we will improve the development of human adaptive immunity. To enable new strains of mice with the
improved human immune system for the studies of human-specific hepatocytes infections, we will introduce
fumarylacetoacetate hydrolase (Fah) gene knockout. Disruption of Fah gene on these new backgrounds will
induce enzyme deficiency, currently regarded as the best model for human hepatocytes engraftment. Combining
strain modifications will facilitate creating a dual humanized mouse model with immune system and liver to study
human-specific infections, therapeutics development, and evaluation of vaccines. We will test our hypothesis by
completing two specific aims: 1) to characterize the development and function of the human immune system in
Nfil3/E4Bp4 knockout NOD/scid mice. Further improvement of human immune system functionality will be
achieved by expressing the human lymphotoxin beta receptor, the chemokine CXCL13, and the thymic stromal
lymphopoietin; 2) To disrupt Fah gene activity on NOD/scid-Nfil3-/- strain using CRISPR/Cas approaches.
Advances in human immune system reproduction will fulfill increasing demands for developing improved animal
models that are more predictable, accessible, and widely applicable for biomedical research.

Public health relevance
Project Narrative: We will create a new genetic background of immune deficient mice to improve their ability to support the development of human lymphoid organs and adaptive immunity to human-specific and emerging infections. New models will reflect the human immunity associated with multiorgan pathology and provide the biomedical community with tools for drug and vaccines discoveries, among other translational research.